DON in Pediatric Cerebral Malaria: A Phase I / II Dose-Escalation Safety Study

Project Summary/Abstract
Cerebral malaria (CM) is defined as an otherwise unexplained coma in a patient with Plasmodium falciparum
parasitemia. The condition is common, primarily affects African children less than five years old, and has a
large public health impact in endemic areas. Of the ~350,000 children diagnosed annually with CM, 15% die
and 30% of survivors have neurological abnormalities at the time of hospital discharge. The mainstay of
treatment is intravenous antimalarial drugs and supportive care. No adjunctive therapy has previously been
proven effective in decreasing the high rates of mortality and morbidity in this condition. Our long-term goal is
to establish feasible therapies that decrease death and disability rates in this vulnerable population.
We will investigate 6-diazo-5-oxo-L-norleucine (DON), a glutamine antagonist, as a candidate adjunctive
therapy for pediatric CM. We identified DON through a rational drug discovery process and tested its efficacy
in several pre-clinical studies. Mice with experimental CM have radiographic and pathological abnormalities
similar to those seen in human pediatric CM; DON administered to mice that are severely clinically ill rescues
animals clinically, radiographically, and reverses abnormal histopathology. We will test DON’s safety and
preliminary efficacy in human pediatric CM. To do so, we will first perform a dose escalation study of DON in
healthy Malawian adults and adults with uncomplicated malaria, evaluating safety. After review, we will
perform a randomized placebo-controlled double-blind safety and preliminary efficacy study of adjunctive DON
in 70 Malawian children with CM. Participants in the first pediatric cohort (n=35) will receive lower doses of
adjunctive DON or placebo. Doses of adjunctive DON administered to the second cohort of pediatric
participants (n=35) will be informed by pharmacokinetic and safety data gathered from those previously
enrolled. Our primary outcome is the proportion of participants with any Grade 3 or severe adverse events
(SAEs). Concurrently with safety studies, DON’s preliminary efficacy in pediatric CM will be evaluated using
brain magnetic resonance imaging (MRI), electroencephalogram (EEG), and transcranial Doppler (TCD). We
hypothesize that Malawian children with CM who receive adjunctive DON will have no increase in mortality or
rates of SAEs compared to participants receiving placebo. We hypothesize that children with CM receiving
adjunctive DON will have biomarker changes (MRI, EEG, TCD) associated with improved outcome.
In summary, this research is significant because the adjunctive therapy, DON, when used in a murine model of
CM, reverses brain swelling, the most important risk factor for death in children with CM. If successful in
subsequent human clinical trials, this would be the first adjunctive therapy with a demonstrable effect on
decreasing death or disability in this patient population. We anticipate that with widespread dissemination of
such a scalable intervention, the public health impact of this devastating infectious disease would finally
decrease.

Public health relevance
Project Narrative To date, there are no adjunctive therapies to reduce pediatric cerebral malaria mortality or morbidity, resulting in enormous economic and public health impacts. This research aims to evaluate the safety and preliminary efficacy of a candidate adjunctive therapy for pediatric cerebral malaria, 6-diazo-5-oxo-L-norleucine (DON). If found safe now, and if future clinical trials confirm clinical efficacy, this paradigm-shifting intervention could be easily implemented by trained medical staff and readily scaled up to impact public health across malaria- endemic countries.